Microglia-Amyloid interactions in delirium superimposed on dementia

ABSTRACT
Impaired cognitive function after common surgical procedures is a growing concern especially among over 5
million people in the United States who suffer from dementia, including Alzheimer’s disease (AD), and thus have
a 3-fold increased risk for fracture requiring surgical repair. After orthopedic surgery, acute changes in cognitive
function, often referred to as postoperative delirium, occur in up to 89% of patients with preexisting dementia,
and associate with poorer prognosis and even 2-fold greater risk for 1-year mortality compared to patients without
dementia or delirium. Our long-term goal is to define the mechanisms that underlie surgery-induced cognitive
dysfunction, and to provide safe and effective approaches to reduce this potentially devastating complication.
From R01-AG057525 we discovered that orthopedic surgery triggers an acute deposition of amyloid-β (A) in
the brains of transgenic Alzheimer’s (CVN‐AD) mice. This proposal continues to characterize the role of innate
immune dysregulation following a common orthopedic surgery (tibial fracture) on the blood-brain barrier (BBB)
and microglial activation using a model of postoperative delirium superimposed on dementia. The overall
objectives are to characterize the immune heterogeneity of delirium superimposed on dementia, and to evaluate
the efficacy of minimally-invasive percutaneous vagus nerve stimulation (pVNS) on microglial function and A
levels in AD-like mice after surgery. Our central hypothesis is that dysregulation of immune cell clusters and
elevated fibrinogen contribute to delirium-like behavior in AD mice after surgery, and that postoperative pVNS
attenuates this effect. This hypothesis is based on preliminary data acquired in the applicants’ laboratories, and
will be tested by pursuing 3 specific aims: 1) Develop a single-cell atlas of the mouse brain with delirium
superimposed on dementia; 2) Analyze the mechanisms of microglial activation and A deposition after surgery
in AD-like mice with delirium; and 3) Define the impact of pVNS on BBB opening and microglial-dependent A
clearance after surgery. Feasibility for these models and techniques has been established in the applicants’
hands. In this innovative approach, we will employ functional transcriptomics with advanced computational
approaches to identify the innate immune single-cell landscape in response to surgical trauma and delirium-like
changes in the brain of dementia-prone mice. We will continue to characterize neuro-immune interactions and
changes in blood-brain function using both animal models as well as organ-on-chip technology. We will also test
the efficacy of pVNS to facilitate A clearance after surgery and limit the onset of postoperative delirium. The
rationale for the proposed research is that successful completion will advance and expand our understanding of
how surgery affects the innate immune system, and will provide new molecular mechanisms of relevance to
delirium, neurodegeneration, and aging. Such knowledge is highly significant because it has the potential to
explain how surgery impacts the vulnerable brain and identify novel targets to prevent postoperative delirium.

Public health relevance
PROJECT NARRATIVE Dysregulated immunity is a hallmark of many neurological disorders including delirium and dementia. Delirium superimposed on dementia remains a poorly understood, life threatening, complication that impacts millions of Americans that require common surgical interventions, such as orthopedic surgery. The proposed research will address this serious public health concern by clarifying molecular and cellular mechanisms that drive the onset of delirium.